Role of the BLA-Insula circuit in stress-induced aversive drinking and negative affective states

PROJECT SUMMARY
In 2023, Alcohol Use Disorder (AUD) affected an estimated 28.9 million people, about 10.5% of the American
population ages 12 and older. AUD has consistently been a public health crisis for many decades, costing the
US economy $249 billion in 2010. The current treatments available are not effective, further warranting
continued work on better understanding the mechanisms and circuits involved in AUD-related behaviors. There
are many factors that contribute to excessive alcohol use, however, one major component that could be
contributing to the development of AUD is stress. While regular stress can drive problematic alcohol
consumption, traumatic stress heightens this correlation and increases the probability of AUD development.
Despite this interaction between stress and alcohol, the circuitry recruited during stress and its persistent drive
on alcohol consumption and negative affect is still largely unknown. The insula is a highly connected region
that is associated with crucial roles in emotional processing and cognitive control. The insula participates in the
brain’s salience network by conveying interoceptive cues to guide behavior through cortical and subcortical
connections. Human imaging studies suggest a decrease in insular volume in alcohol dependent patients,
further implicating the insula’s larger role in AUD-related behaviors. We have shown that the insula is important
in regulating negative affective states during abstinence and coping behavior during a stressor. To better
understand the insular circuitry recruited during stress, we aimed to identify all upstream inputs onto stress-
activated insula neurons using a FosTRAP mouse model and a retrograde viral approach with whole-brain light
sheet microscopy. Insular stress ensembles receive the densest projections from the basolateral amygdala
(BLA), a region involved in modulation of anxiety-like behaviors, alcohol consumption, fear conditioning, and
emotions. This proposal aims to characterize the role of the BLA-insula circuit in traumatic stress-induced
negative affective states, binge-like, and aversive drinking by using validated preclinical models of PTSD and
alcohol drinking, Single Prolonged Stress (SPS) and drinking in the dark (DID), respectively. We will first
establish the BLA-insula pathway’s role in stress valence and AUD-related behavior by using chemogenic
manipulation during SPS and probing for affective states and alcohol consumption following stress. Next, we
will correlate the physiological stress response with neuronal activity in the BLA-insula pathway during
withdrawal from alcohol. To complement, we will use in vivo fiber photometry to measure calcium activity in the
BLA terminals present in the insula during drinking following stress. We predict valence of traumatic stress is
encoded by the BLA-insula pathway, leading to the initiation and maintenance of alcohol consumption, even in
aversive conditions. The studies proposed here will provide a more complete perspective on the interaction
between stress and the development of AUD, leading to fruitful contribution to better our treatment options.

Public health relevance
PROJECT NARRATIVE Problematic alcohol use as a consequence of traumatic stress represents a risk factor for the development for Alcohol Use Disorder, with heightened symptom severity, and enhanced negative affect. Despite this interaction between stress and AUD, the underlying mechanisms and circuits involved in stress induced alcohol consumption are not fully understood. This proposal will combine animal models of traumatic stress and binge-like and compulsive drinking to further discern how the BLA-insula pathway might be implicated in alcohol related behaviors following stress by using cutting-edge techniques like chemogenetics and in vivo fiber photometry.